Irx1 regulation of oral tissue repair and maintenance.

Project Summary
Oral disease causes a significant burden on overall health and 3.9 billion people are affected
worldwide. Oral diseases such as periodontitis, cancer, tooth loss, craniofacial birth defects and pain all affect
growth and maintenance of the oral cavity and oral mucosa. Improving oral wound healing due to diseases,
chronic wounding and scarring would greatly affect quality of life. The oral mucosa is primed with wound-
activated gene signatures to facilitate the rapid and scarless wound healing. However, the genetic and
molecular mechanism underlying this process is still largely unknown. We have found that Iroquois Homeobox
1 (IRX1/Irx1) is expressed in the basal layer of gingival epithelium and cell populations in the mesenchyme in
both murine and human samples, which indicates its potential role in regulating gingival wound healing.
Moreover, Irx1 expression may mark potential stem cell niches in the basal cell layer of the oral epithelium.
We are investigating the role of Irx1 in epithelial basal cells during gingival wound healing utilizing our
mouse gingival injury model. We have previously reported that Irx1 is expressed lung stem cells. By analyzing
the wound healing progression and lineage tracing of basal cell activity during gingival wound healing, our
preliminary data suggests that re-epithelialization is negatively affected during gingival wound healing in adult
Irx1+/- (Het) mice, as indicated by delayed wound closure, delayed structural changes in regenerated
epithelium and altered differentiation of keratinocytes. The transcriptomic analysis revealed a wound
associated gene signature in the Irx1+/- epithelium. In preliminary studies, Irx1 was identified as a new gene
that is primed at the base of the gingiva, which may facilitate rapid and scarless wound healing through the
EGF signaling pathway.
To determine if Irx1 regulates a progenitor cell niche in the oral cavity we propose three specific aims.
1) Determine the expression pattern of Irx1 during embryogenesis and homeostasis in potential progenitor cell
niches in the oral cavity; 2) Identify the role of Irx1 in oral tissues using inducible Cre models for lineage
tracing; 3) To analyze the effects of oral wound healing regulated by Irx1.

Public health relevance
Narrative This project will determine if oral wound healing is regulated by Irx1, a new progenitor cell transcription factor. Irx1 may mark oral stem cell niches and regulate cell proliferation and differentiation of cell types in the oral epithelium. This study will determine if Irx1 controls the repair and regeneration of the oral epithelium.